Fetal/Neonatal/Childhood Effects Of In Utero PCB DDE

The long-term effects of in utero exposure to organochlorine compounds is of great potential importance. These compounds, which are detectable in nearly 100% of humans worldwide, have been linked to impaired neurodevelopment in children. In addition, p,p'-DDE, the primary metabolite of DDT, is a weak estrogen, and an androgen receptor blocker at concentrations observed in humans. One objective of this project is to determine whether maternal serum concentration of DDE, obtained during pregnancy, is a risk factor for cryptorchidism, hypospadias and polythelia in male offspring. These malformations were chosen because they are markers of deficient androgen activity in utero. Other objectives are to determine whether in utero exposure to DDE is subsequently associated with an altered age at menarche in adolescent females and an increased risk of obesity in adolescent males, and whether in utero exposure to PCBs is associated with suboptimal muscle tone, reflexes, IQ and hearing during childhood. Work to date has demonstrated that these compounds can be recovered from the study population at relevant concentrations, and that the correlation between concentrations of these compounds in first and third trimester serum is sufficiently high to employ third-trimester serum as a surrogate for first-trimester exposure. Work completed in FY 2005 found that elevated maternal serum PCBs were not associated with childhood neurodevelopment, fetal growth or duration of pregnancy, time to pregnancy or sensorineural hearing loss, but are associated with abnormalities of the menstrual cycle, that maternal serum DDE is associated with history of fetal loss increased time to pregnancy, and reduced childhood growth at the highest levels. Neither maternal serum DDE nor PCBs were associated with pubertal development nor size in adolescent males.